Analysis of polygenic disease risk and etiology by indexing ancestry- and gender-specific gene variants predicted to impact function

Identification of genes associated with polygenic diseases is challenging in part because such diseases may be also greatly influenced by environmental and behavioral factors. To overcome these challenges, a deeper understanding of how ancestry-and gender-associated genetic variance affects disparities in the disease risk is merited. Better understanding of such genetic variance may also facilitate the identification of polygenic disease-associated genes. We hypothesize that the discovery of genes associated with polygenic diseases may be limited by over-reliance on single-nucleotide polymorphism (SNP)-based genomic investigation, since most significant variants identified in genome-wide SNP association studies map to introns and intergenic regions of the genome. To overcome such potential limitation, we are developing gene-constrained and function-based analytical methods centered on high-risk variants (hrV) that encode frameshifts, stopgains, or splice site disruption, but that may also consider variants with potentially lesser impact such as variants that encode missense mutations. Function-based and ancestry- and gender-specific analysis of genetic variations may accelerate the identification of genes associated with polygenic diseases that are also greatly influenced by environmental and behavioral factors, such as type 2 diabetes mellitus (T2DM), obesity, hypertension, and Alzheimers disease.